Immune Tolerance Network UM1 2023 Supplement

Project Summary / Abstract
The mission of the ITN is to advance the clinical application of immune tolerance by performing
high quality clinical trials of emerging therapeutics based upon testable mechanistic hypotheses.
The ITN is structured in order to interrogate different diseases across the immunologic
spectrum, with integration of innovative clinical studies and cutting edge immunology laboratory
analysis. The ITN approach—clinical assessment of novel tolerance therapeutics, while we
simultaneously evaluate the cellular, genetic, and immunologic mechanisms of disease and how
they are altered in response to therapy—creates a framework for advancing cross-disease and
cross-discipline knowledge, all designed to accelerate therapeutic options for major diseases.
The existing scientific and operational framework enables the ITN to successfully enhance the
development of tolerance therapies in transplantation, autoimmunity, and allergy. ITN has
outlined a process to evolve our current strategies into the next generation of planned trials, as
well as to operate a nimble, future-focused organization, poised to lead and adopt innovations
that are currently unknown. The ITN has a collaborative structure involving hundreds of
investigators, advisors, and clinical sites working in tandem with a core group of ITN staff,
operating a program that is both scientifically and financially efficient. Several new innovations
recently adopted by the ITN encourage widespread involvement from academic investigators,
including expanded resource sharing and data sharing operations. With lead institutional
commitment from the Benaroya Research Institute and the University of California San
Francisco, and participation of more than 20 other major institutions represented in leadership
and major advisory roles, the ITN strives to continue to successfully pioneer high impact clinical
trials and mechanistic studies in areas of unmet medical need.

Public health relevance
Project Narrative The proposed ITN UM1 funding addresses major unmet health needs. In the United States, autoimmune diseases affect >5% of the population, and allergic diseases affect another ~15%. Transplantation is a life- saving intervention for organ failure, but risky and burdensome. In each area, pre-clinical studies show that immune tolerance should be an achievable therapeutic prospect, and progress towards that goal is evident in recent clinical trials. Successful tolerance offers long-term freedom from immunosuppressive therapy, radically improving quality of life, disease burden, and health care costs.